Probing and modeling decidual natural killer cells in preterm birth

Project Summary/Abstract
The human placenta is a semi-allogeneic tissue whose growth and development requires tolerance by the
maternal immune system. How this relationship is compromised in the setting of spontaneous preterm birth
(sPTB) is currently unknown. In a normal pregnancy, placental cells come in close contact with maternal blood
and uterine tissues yet are able to evade immune recognition throughout gestation. During this time, the maternal
immune system maintains a balance of tolerance toward foreign fetal alloantigens while simultaneously staging
a response to potential pathogens at the maternal-fetal interface. The nature of such maternal-fetal cellular
interactions is poorly understood, particularly when it goes awry in the setting of spontaneous preterm birth
(sPTB). The uterine lining, called decidua, is a particularly understudied microenvironment, containing many
maternal immune cells, of which decidual natural killer (dNK) cells are the most abundant. It is at this interface
where placental cells called extravillous trophoblast (EVT) come in close contact with maternal immune cells.
Invasion of the decidua by fetal EVT is required for proper remodeling of the maternal uterine lining, including
vascular remodeling which leads to establishment of maternal blood flow to the placenta. Interactions between
placental EVT and decidual leukocytes, such as dNK, are known to facilitate maternal vascular remodeling by
EVT and limit the extent of EVT invasion into the uterine wall. Indeed, problems in sPTB could result from
inappropriate responses by dNK cells. Unfortunately, dNK function, including dNK-trophoblast crosstalk, is
difficult to study in an ongoing pregnancy, due to lack of access to the decidual compartment, where these
important interactions occur. Additionally, very few studies have characterized dNK at term when the pregnancy
outcome is known. While animal models have offered some insights into these processes, they do not accurately
model human placentation and pregnancy. This proposal aims to functionally and transcriptomically characterize
dNK subpopulation(s) in term, with or without labor, and preterm placenta, then use induced pluripotent stem
cells (iPSC) to model dNK, in the setting of both term and preterm birth. Our team has established optimized
methods for differentiation of iPSC into both peripheral blood NK cells and EVT. We will now optimize a protocol
for iPSC differentiation into decidual NK cells, comparing them directly to primary cells. Successful completion
of this proposal will reveal underlying mechanisms through which abnormal dNK activation contributes
to spontaneous preterm birth, and establish a renewable and manipulatable model of dNK at the human
maternal-fetal interface.

Public health relevance
Project Narrative Proper interaction of placental cells with the maternal immune system is required for induction of tolerance and a successful pregnancy, but this process goes awry in spontaneous preterm birth. We propose to characterize decidual natural killer (dNK) cell heterogeneity and function in both term and preterm birth. We will then apply these findings from primary dNK cells to induced pluripotent stem cells in order to establish a renewable resource for optimal study of these cells and their interactions with placental cells at the maternal-placental interface.